EPHEDRINE AND LOW CARBOHYDRATE DIET FOR LATE ONSET ACID MALTASE DEFICIENCY

The aims of this protocol are to determine the clinical, biochemical, muscle strength, muscle function, pulmonary function, EMG, and molecular genetic status of acid maltase deficiency patients. Interventions such as low carbohydrate diet, moderate daily exercise, and daily oral ephedrine therapy will be assessed at designated intervals.